Dynamic single-cell analysis instrument to evaluate immune cell function

The goal of this Fast-Track SBIR is to manufacture Chronos: a dedicated instrument for image-
based dynamic, functional single-cell analysis for use with the CellChorus® TIMING™ (Time-
Lapse Imaging Microscopy In Nanowell Grids) platform. The TIMING technological platform is
also being validated by academic and commercial entities through peer-reviewed publications,
presentations, and commercial contracts through the CellChorus Early Access Program, including
new abstracts and publications by CellChorus and the lab from which we spun out. Importantly, a
recent publication in Nature Cancer shows that TIMING can be used to identify the most potent
cytolytic CAR T cells among populations of infusion products (Rezvan et al, Nat Cancer 2024).
TIMING encompasses 1) plating cells in nanowells arrayed in grids of 5,000-10,000 nanowells;
2) rapid and gentle time-lapse imaging over hours with multiple light channels; and 3) AI-powered
analysis of cell behaviors. This project addresses the second part of the platform (2) by creation
of Chronos, an enclosed imager with the key features needed for users to very easily run TIMING
assays without needing advanced microscopy training.

Public health relevance
Research Plan Narrative (administrative supplement) We are part way through the first year of the Phase II SBIR project. The aims have not changed, and the proposed costs are for replacement of outdated equipment and for additional accessories or measurement tools. Replace obsolete equipment. We request funds to replace outdated cell culture equipment necessary to prepare cells for time-lapse assays to be run in Chronos instruments. (no change in scope; see additional justification for the equipment in the Budget Justification). This will include addition of intensity standards to ensure and track uniformity of cell staining when testing Chronos beta instruments. This is crucial, as the light sources, optical train, and camera are different in beta instruments. We are also adding consumables for the Countess 3-fl. We will quantify the cell intensity on different batches of cells to validate the cell staining protocol needed for users to input cells into Chronos. Additional Chronos tools. We will work with our existing contract manufacturer (Manta) to develop an SBS-standard footprint adapter for our custom TIMING nanowell chamber slides that are to be used with Chronos. We did not realize how important it is for the chamber slide to be held tightly and completely flat. We have identified numerous issues with current slide holders on other instruments and within different environmental chambers. This adapter will allow direct comparison of Chronos with existing commercial microscopes in different institutions to help show the value to customers. We envision the adapters will become a new marketable product. The scope of work and work plan is described by Manta in the attached quote. Measurement tools. We had not anticipated the need for specific metrology sensors to ensure exact alignment and spacing during manufacture and after shipping to the CellChorus lab and customer lab test sites. This is not a change in scope. Zeiss ZEN software. As noted in the budget justification, we require a dedicated and current ZEISS software license to optimally control the Chronos alpha for comparisons with the beta instruments. We had not anticipated this cost for the alpha project. Additional comments are included in the Budget Justification document.